A multi-component non-pharmacological intervention to improve cognitive outcomes in hematologic cancer survivors

PROJECT SUMMARY / ABSTRACT
Cognitive impairment is a well-established adverse outcome in survivors of hematologic malignancy (HM) treated
with and without blood or marrow transplantation (BMT). Cognitive impairment significantly challenges survivors’
independence and ability to return to work, in addition to reducing their ability to follow complex treatment
management plans which has been associated with worse survival outcomes in older adults with HM. In a large
prospective study of HM patients treated with BMT, we found a high prevalence (up to 36%) of global cognitive
deficits, which persisted up to 3y. Older age, male sex, lower education and income, lower cognitive reserve, as
well as genetic variants on blood brain barrier, telomere homeostasis, and DNA repair genes were associated
with increased risk of cognitive impairment. In order to address the need to mitigate the risk of cognitive deficits,
we conducted a study to examine the feasibility of a 12-week, home-based, cognitive training intervention in HM
patients treated with allogeneic BMT. To date, we have enrolled 43 evaluable patients, achieving 60.4% consent
rate, 77.3% randomization rate, 20.7% post-randomization attrition and median intervention adherence of 83.3%.
Preliminary results show an intervention effect in improved processing speed (p=0.006) among patients with
baseline impairment. Cognitive function, however, is a complex phenotype involving several domains best
tackled using a multi-component approach that involves both compensatory (e.g. cognitive training) and
enhancement of molecular pathways (e.g. nutritional ketosis) mechanisms. Ketogenic interventions have
consistently shown cognitive improvements as early as 6-8 weeks in the non-oncology space including patients
with mild cognitive impairment, Alzheimer's disease and dementia. While the brain's ability to use glucose as an
energy source is reduced with aging; circulating plasma ketone bodies are an effective alternative due to their
water solubility and ability to cross the blood brain barrier. In addition, nutritional ketosis upregulates DNA repair
pathways, enhances synaptic plasticity, and reduces inflammation. These effects on cognitive outcomes in HM
survivors have not been explored. We aim to explore the feasibility of integrating exogenous ketogenic
supplementation to the existing 12-week cognitive training intervention, examine intervention effects using
objectively measured cognitive function, and examine the sustained effects of the multi-component intervention.
The study will be conducted by a qualified multidisciplinary team of investigators with experience in intervention
and cancer survivorship research at the University of Alabama at Birmingham. Our established feasibility of
enrolling survivors in the cognitive training intervention provides the needed infrastructure to test these aims with
the future goal of implementation of a definitive multi-component cognitive randomized clinical trial in HM
survivors.

Public health relevance
PROJECT NARRATIVE Effects of treatment of hematologic malignancies (HM) on the brain and cognitive functioning is an area that has garnered a lot of interest in recent years with accumulating evidence showing a high prevalence of persistent, long-term cognitive impairment among survivors. This study is a randomized waitlisted intervention to test whether HM survivors would benefit from a multi-component intervention combining compensatory and metabolic mechanisms aimed at improving cognitive function. The program is delivered via a novel, home- based approach which if proven feasible will allow for future implementation of a definitive trial to assess efficacy of the multi-component intervention program.